EFFECTS OF ERYTHROPOIETIN ON THE TRANSFUSION REQUIREMENTS OF EXTREMLY LBW INFANTS

The purpose of this study is to determine if the administration of Epo to ELBW infants will result in an increase in their reticulocyte counts and hematocrits, and a decrease in their transfusion requirements during the first three weeks of life in a cost-effective fashion.